A Large-scale Efficacy Trial of a Resilience Training Program for First Responders

Project Summary. As a result of chronic exposures to traumatic and stressful events, first responders are at
elevated risk for experiencing post-traumatic stress disorder (PTSD) and other mental health problems.
Resilience training can reduce the risk for developing mental health symptoms in first responders. The National
Institute for Environmental Health Sciences and the Substance Abuse Mental Health Services Administration
developed the Worker Resilience Training (WRT) program – a 4-hour interactive workshop to educate
responders on the effects of traumatic exposures, PTSD and ways to increase adaptive coping resources and
promote resilience. We completed a randomized clinical trial (RCT) of the WRT for active responders (n = 167).
Results indicated that the WRT, as compared to a waitlist control group, helped prevent the development of
PTSD and depression symptoms, and improved important resilience indicators (i.e., healthy lifestyle behaviors,
stress management, physical activity) over the course of three months. The proposed multi-site RCT seeks to
build on our initial study by conducting a Stage III efficacy trial of the WRT workshop in N=800 first responders
in four demographically similar counties in New York (NY) and Houston, TX. Our specific aims are: Aim 1. To
evaluate the efficacy of the WRT program for improving resilience indicators, defined as health promoting lifestyle
behaviors, stress management and physical activity, and improving perceived resilience over the course of one
year. Aim 2. To evaluate whether the WRT program serves to prevent the development or worsening of
psychological symptoms and impairments in functioning over the course of one year among those first
responders who are exposed to traumatic events after participation in the study workshop. Aim 3. To identify the
target treatment mechanisms of the WRT (i.e., skills practice, promoting healthy behaviors, stress management,
physical activity and perceived resilience) for preserving mental and occupational health outcomes and
functioning over the course of one year in first responders who are exposed to traumatic events post-workshop.
We will use a cluster RCT design and multi-modal assessments including self-report measures, a web-based
stress reactivity performance task, and real-time accelerometry. Participants in both conditions will also receive
a booster session at 3 months post workshop to reinforce skills and intervention knowledge. Overall, this study
will contribute to our understanding of how resilience training may serve to protect the mental health and
functioning of first responders. This study has important clinical and public health implications, including
preserving and strengthening mental health and reducing overall personal and financial costs to first responders,
their family and the community at-large. This study also takes a research to practice approach by working
collaboratively with fire departments and EMS organizations
from four demographically similar counties in NY
and Houston, TX. If successful, we will work with these leaders to develop a method for annual WRT trainings
to foster resilience and promote well-being long-term for first responders.

Public health relevance
Project Narrative. The proposed research is relevant to public health by providing a large-scale efficacy test of the Worker Resilience Training (WRT) program – a novel resilience building workshop for first responders. This test will provide critical information necessary to understand the mechanisms of the WRT for preserving mental health outcomes over the course of twelve months. Overall, the current proposal will strengthen the evidence base for utilizing the WRT program to prepare and protect first responders from the effects of traumatic exposures.